Dual Beckman Coulter DxH 690T and Beckman Coulter DxH 560 AL

Abstract
Texas Biomedical Research Institute (Texas Biomed) is a non-profit, independent research institute, focused on
infectious disease research. It is also the host institution for the Southwest National Research Primate Center
(SNPRC), one of the seven NIH-funded NPRCs in the nation. SNPRC houses ~ 3000 nonhuman primates
(NHPs). The SNPRC Pathology Core supports diagnostic, anatomic, morphologic, molecular and clinical
pathology needs of > 100 internal and external scientists. Many internal faculty members also extensively
utilize rodents for research that is supported by the Pathology Core staff. We request S10 support to purchase
a dual Beckman Coulter DxH 690T and Beckman Coulter DxH 560 AL for hematology analyses of
experimental and colony health data of NHPs and rodents. The requested replacement unit will replace and
upgrade the clinical diagnostic services that are currently provided by end-of-life equipment at Texas Biomed.
The DxH 690T is a suitable, cost-effective replacement for, and is capable of reproducing all analysis parameters
of an existing DxH 800. The DxH 560L performs hematology analysis using miniscule volumes of blood, which
makes hematology analysis possible for studies involving rodents and small NHPs.

Public health relevance
Narrative Texas Biomedical Research Institute, the host institution of the Southwest National Research Primate Center (SNPRC), is home to 3,000 NHP and 4,000 rodents. The SNPRC Pathology Core is critical for diagnostic support for the continued maintenance of healthy NHP and rodent colonies, and to provide advanced molecular pathology support for research studies. To continue to provide reliable clinical pathology services and to extend the hematology services to the growing small NHP and rodent colonies at Texas Biomed, this application seeks support for replacement of an end-of-life hematology analyzer with a dual Beckman Coulter DxH 690T and Beckman Coulter DxH 560 AL hematology analyzer.